An implementation science approach to the design and evaluation of tuberculosis self-testing

Tuberculosis (TB) remains a major global health crisis, causing 10 million new cases in 2023. Despite extensive efforts by the global community to identify TB cases, 30% of new cases went undiagnosed. Current strategies focus on active case finding, which is costly and hard to implement practically. One potential solution to these challenges is self-testing. Although self-testing for TB has not been widely adopted so far, partly due to a lack of suitable testing options and studies evaluating this method, recent advances in diagnostic technology make self-testing a feasible option. This development opens a new avenue for patient-centered TB care.
I propose a type 3 hybrid implementation-effectiveness study to assess the feasibility of implementing self-testing for active TB. I will use a currently available diagnostic tool—oral swab specimens for molecular testing—which are easy to self-collect and sensitive but require shipping to a laboratory. I have identified barriers to TB self-testing implementation and will refine strategies to address these barriers through qualitative interviews and quantitative surveys (Aim 1). I will conduct a prospective study in high-burden community settings in Baltimore, U.S., where known TB contacts and/or working-age individuals are less likely to seek care, distributing oral swab kits in intervention facilities while maintaining TB training standards in comparison facilities (Aim 2). I will evaluate the implementation and effectiveness of each strategy guided by the Reach, Effectiveness, Adopt, Implementation, and Maintenance (RE-AIM) framework. My primary outcome will be an increase in the proportion of individuals receiving microbiological testing results, reflecting the acceptability and fidelity of TB self-testing. To achieve these aims, I will employ a highly pragmatic study design in which the research team minimizes contact with study households. This approach will allow me to evaluate whether TB self-testing implementation can impact case detection and improve health outcomes for individuals in a “real-world” setting. Completing this study will provide pragmatic, preliminary data on the potential implementation and effectiveness of TB self-testing in high-burden settings. If successful, it will justify a larger trial; if not, it will inform alternative strategies to overcome barriers to seeking TB care. In either case, the findings will motivate a larger R01 proposal at the end of the five-year grant period and advance the field of TB self-testing.
While this proposal will assess self-testing using an available tool, a broader goal is to develop a self-testing strategy for TB disease that can be applied to future tools. This approach aims to advance patient-initiated or patient-centered TB care. Additionally, the study will help me gain skills in mixed methods research and implementation science, positioning me as a future leader in implementing patient-centered TB interventions globally.
Modified

Public health relevance
Public Health Relevance/Narrative Section Despite recent advances in diagnostic testing, nearly three million people develop active tuberculosis (TB) each year but are not properly diagnosed, partly due to limited evidence on how to implement patient-centered case-finding strategies. Self-testing is an innovative approach that has successfully improved the diagnosis of infectious diseases like HIV, yet it has not been widely adopted for TB so far. In this project, I will receive the training needed to become a leader in TB self-testing by conducting a combined implementation and effectiveness evaluation—guided by formative qualitative evidence—of two TB diagnostic assays (oral swab for molecular testing) used for self-testing at six facilities serving vulnerable populations in Baltimore, U.S.